New Jersey Department of Agriculture LFFM Project for Integrated Food Safety

Project Summary (Overall)
The New Jersey Department of Agriculture (NJDA) laboratory would like to participate in the
Laboratory Flexible Funding Model (LFFM) projects to improve animal food surveillance by
obtaining laboratory equipment, supplies, personnel, and training in standardized testing
methodologies and quality assurance. Participation in the LFFM will enhance the animal food
analytical capabilities of the NJDA laboratory and help maintain the ISO 17025:2017
accreditation. The LFFM co-operative agreement program will help the NJDA laboratory
develop and maintain analytical methods needed by the Food and Drug Administration (FDA)
and the New Jersey State animal food regulatory agency (Division of Marketing and
Development), undertake proficiency testing provided by external agencies, and implement an
annual animal food sampling plan. The laboratory will be able to provide defensible laboratory
data for regulatory action. The NJDA laboratory will be able to enhance animal food testing
capacity and capability by performing whole genome sequencing of the food-borne and related
bacterial isolates. The laboratory will share testing and sequencing data with the FDA. The
laboratory will develop the capacity to provide analytical services during a large-scale
microbiological or chemical event through contaminated animal food. The laboratory will also
participate in a mentoring program in collaboration with the FDA and other participating
laboratories. Overall, the LFFM co-operative agreement program will enable the development of
integrated laboratory science and food safety in New Jersey and the United States to support
the Food Safety Modernization Act (FSMA).

Public health relevance
Project Narrative (Overall) The Laboratory Flexible Funding Model (LFFM) co-operative agreement program will provide equipment, supplies, personnel, and training in standardized testing methodologies and quality assurance. These provisions will enhance the New Jersey Department of Agriculture's (NJDA) capabilities in animal food sample analysis, molecular epidemiology, outbreak response, and surveillance testing. The NJDA’s participation in the LFFM will help strengthen the nationwide integrated laboratory sciences and food safety supporting the Food Safety Modernization Act (FSMA).